UAB Diabetes Research Center

This proposal will continue progress of the UAB DRC first established in 2008. Our mission is: “Alleviate
suffering and the social burden caused by diabetes and cardiometabolic disease through innovative,
multidisciplinary, basic and translational research and research training, which advances understanding of
disease mechanisms, prevention, and treatment”. Over 14 years, the DRC has galvanized the UAB research
efforts around the study of diabetes and established an outstanding research community that has grown to 150
scientific investigators with current extramural diabetes research funding of $91,388,610 annual direct costs. Our
center’s goals are to facilitate excellence in diabetes research, further develop a cohesive intellectual community
promoting collaboration and innovation, and provide an outstanding environment for training and career
development. Our research emphasizes the study of diabetes as both a metabolic and vascular disease and
includes areas of research excellence including molecular signaling, islet biology & autoimmunity, integrative
metabolism, vascular disease/inflammation, diabetes complications, genetics & epidemiology, and interventions
& community based research. Our specific aims are to:
1. Facilitate and enhance diabetes research by sponsoring research core facilities expressly required by
our investigator base and that cover a broad translational spectrum: Animal Physiology, Human Physiology, and
Interventions & Translation Cores.
2. Augment diabetes research via a pilot & feasibility grant program that will emphasize innovation,
translation, and career development of highly promising junior investigators.
3. Sponsor an integrated Enrichment Program that promotes a cohesive environment for an outstanding
multi-disciplinary investigator base, which will enhance learning, training, collaboration, collegiality, and
innovation.
4. Emphasize research and outreach that are responsive to the needs of our trainees, achieve better
outcomes for our patients, and lessen the high burden of diabetes in our community and nation.
5. Respond to the evolving needs of our investigators and through leadership that impels new ideas and
lines of investigation, and leverage the resolve of UAB leadership, substantial institutional commitments, and
generous philanthropy from our community to further impel the development of a pre-eminent center of diabetes
research excellence in the heart of the Deep South.
The DRC has exerted a pronounced impact on diabetes research excellence at UAB in a community with the
highest rates of diabetes in the US, and has united investigators around common themes to study diabetes in
the context of cardiometabolic disease. We are confident that further evolution and growth will be achieved over
the next 5 years.

Public health relevance
The UAB DRC is the only NIDDK diabetes center located in the Deep South, at the 'Diabetes Belt' epicenter characterized by the highest rates of diabetes in the US. Through its core facilities, pilot grants, and enrichment activities, the Center has developed an effective strategy for promoting excellence in diabetes research, new discoveries, and a strong environment for training the next generation of research leaders. Thus, the UAB DRC endeavors to develop better ways to prevent and treat diabetes, and lessen the burden of patient suffering and high social costs of diabetes.